Engagement and Dissemination Core

Project Summary/Abstract
Rare diseases (RD) and disorders collectively affect up to 30 million Americans. RD research faces key
challenges: 1) insufficient knowledge about the etiology, pathophysiology, natural history and epidemiology
of the diseases; 2) inadequate or non- uniform case definition and disease classification systems that make
diagnosis and epidemiologic assessment difficult; 3) insufficient understanding of the determinants of
multiple phenotypes and the relationships between genetic variance and phenotypic manifestations; 4)
rarity and geographic dispersion of cases that hampers both access to qualified care and participation in
research; 5) a dearth of clinically proven, safe and effective treatments; and 6) inadequate private
investment into RD research and treatment. The Rare Diseases Act of 2002 authorized the Office of Rare
Disease Research to recommend a research agenda and promote coordination and cooperation among
research programs. The Rare Diseases Clinical Research Consortia (RDCRCs) that comprise the Rare
Diseases Clinical Research Network (RDCRN) advance the diagnosis, management, and treatment of RDs
to enhance clinical trial readiness. The RDCRN Data Management and Coordinating Center (DMCC) must
provide state-of-the-art informatics, statistical and epidemiological expertise in clinical research study
design and data management in order to support the production of evidence that can support the
progression of rare disease clinical research (RDCR). To achieve clinical trial readiness (CTR) throughout
the RDCRN, we will continue to lead the DMCC based at Cincinnati Children’s (CCHMC) pursuing three
Aims: 1) To advance the methods and practice of RDCR and promote CTR through the effort of our Clinical
Research Core (CRC) and Data Management Core (DMC); 2) To maintain and enhance a leading-edge,
cloud-based data ecosystem to facilitate the research performed by the RDCRCs and promote data sharing;
and 3) To expand research collaboration within the RDCRN and with other stakeholders and disseminate the
RDCRN research findings, promoting the RDCRN globally. The DMCC Administrative Core will maintain an
efficient organization of the DMCC, support RDCRN governance and promote collaboration across the
RDCRN; the Data Management Core will support the RDCRN Operational Environment will facilitate FAIR
data sharing in the RDCRN Data Repository; the Clinical Research Core that will advance CTR and best
practices in RDCR, and will offer training through a methodology hub; the Engagement and Dissemination
Core will implement a broad RDCRN outreach and dissemination program, engage the PAGs in RDCR, and
offer opportunities for career enhancement. We rely on a combination of world-class expertise, outstanding
infrastructure, state-of-the-art technology and enthusiastic institutional support. We will hasten scientific
discovery within the RDCRN and bring new treatments to trial, ultimately promoting health and wellness for
RD patients and their families.

Public health relevance
Project Narrative The Data Management and Coordinating Center (DMCC) of the Rare Diseases Clinical Research Network (RDCRN) at Cincinnati Children’s will enhance clinical trial readiness by advancing the methods and the practice of rare disease clinical and research (RDCR). The DMCC will develop and share knowledge accumulated by the RDCRN, including research data, study findings, and best practices, for use by all stakeholders studying, treating, or adversely affected by rare diseases. We will catalyze shared participation in order to transform the RDCRN into a collaborative dedicated to the goal of better, faster, more impactful RDCR.